In Situ Skin Regeneration and Angiogenesis for Full-Thickness Burns

Prompt closure of wounds is critical to prevention of infection and sepsis in patients suffering massive burn
injuries. The most common challenge associated with treating these patients is the lack of available donor skin.
Although new technologies are emerging to treat deep partial thickness burns, only one is commercially available
for the treatment of full-thickness burns (cultured epithelial autografts, CEAs). CEAs are a life-saving treatment
option; however, they are extremely fragile, prone to damage and require > 3 weeks to manufacture. As early
wound closure reduces the risk of infection, fluid loss, mortality and scarring, strategies to quickly and
permanently close full-thickness wounds are needed to increase survival and improve outcomes. The current
obstacles to rapid in situ regeneration of full-thickness wounds using cell sprays include the lack of viable dermis,
low engraftment efficiency and variable survivability of spray-on cells. Our team recently developed allogeneic
dermal substitutes with laser ablative dermal papillae that significantly enhanced keratinocyte proliferation. This
regenerative platform, consisting of freshly isolated autologous cell sprays and an off-the-shelf, allogeneic dermal
template with laser micropatterned dermal papillae and growth factor loaded rapid release nanoparticles, is
proposed to facilitate rapid, permanent wound closure via enhanced adhesion and survival of spray-on skin cells
and rapid angiogenesis. In Aim 1, spray-on skin cell engraftment and survivability will be examined as a function
of the form of the laser micropatterned dermal papillae (width, length, angle). Aim 2 seeks to further enhance
spray-on skin cell survivability and epidermal regeneration via enhanced angiogenesis. The role of vascular
endothelial growth factor (VEGF)/ platelet-derived growth factor (PDGF)-releasing, high surface area to volume
polydopamine (PDA) nanoparticles on the rate and extent of angiogenesis and downstream epidermal
regeneration will be assessed in a mouse model followed by a highly translational porcine model. In Aim 3,
gradient collagen-silk scaffolds will be fabricated to reduce contraction of the wounds while providing a physical
and chemical environment that promotes epidermal regeneration. Finally, the efficacy of the fully optimized laser
micropatterned dermal template (dermal papillae form, VEGF/PDGF-PDA loading and concentration and
scaffold mechanics) will be examined in a porcine burn model compared to standard autografting and spray-on
skin cells alone. The proposed studies leverage the expertise in regenerative medicine, vascularization and large
animal models to develop a novel, immediate use technology that can dramatically transform treatment for
patients suffering from massive burn injuries and improve outcomes and quality of life.

Public health relevance
Treatment of large, third degree burns presents a number of challenges including the low availability of remaining healthy skin for grafting, delayed wound closure and extended hospital stays. Although rapid closure is associated with lower mortality and less scarring, available treatments require extensive manufacturing times, delaying closure. This project seeks to improve outcomes for burn patients by developing technologies to facilitate regeneration of full-thickness skin on the patient’s body without culture, leading to rapid wound closure and reduced scarring.